Histology, Imaging, and Analysis Module

SUMMARY – HISTOLOGY, IMAGING, AND ANALYSIS MODULE
The Histology, Imaging, and Analysis (HIA) module gives supported faculty and their laboratory members
access to facilities, services, training, and expertise in sample preparation and labeling, imaging, and image
analysis. The module provides resources for a single workflow, from tissue sample preparation to generating
numerical data from high-quality images. Included in the module are equipment and technical expertise for
histologic processing, embedding, sectioning, staining, and labeling, as well as microscopic techniques
including brightfield, darkfield, polarized light, fluorescence, phase contrast, and DIC microscopy, as well as
live cell microscopy. Qualitative and quantitative analysis techniques are provided with an emphasis on
imaging ethics and scientific integrity. This essential equipment and support facilitate research for numerous
NEI-funded projects, and for new faculty to acquire preliminary data for R01 grant applications.